Advancing Minnesota' Efforts Towards a Nationally Integrated Food Safety System

Project Abstract
This cooperative agreement is intended to support the Manufactured Food Regulatory Program
Standards (MFRPS), Rapid Response Teams (RRT) and Food Protection Task Force (FPTF)
Programs, as well as Special Projects supporting these programs. The intended outcome of this
FOA is to advance efforts for a nationally integrated food safety system (IFSS) by assisting state
programs in achieving and maintaining conformance with the MFRPS, establish and/or support
a Food Protection Task Force, facilitate long-term improvements and innovation by unifying and
coordinating federal/state/local human and animal food response efforts, and support innovation
and integration in an IFSS using the MFRPS or RRT framework for special projects.
The Minnesota Department of Agriculture (MDA) Food and Feed Safety Division (FFSD)
licenses and inspects approximately 10,000 food facilities including 2,000 manufactured food
facilities in Minnesota. The MDA-FFSD has a dedicated Manufactured Food Program
responsible for manufactured food licensing, compliance, and inspection activities. The
Manufactured Food Program has 16 staff members including one program manager, two food
supervisors, one dedicated support person, and 12 field inspectors. FFSD has an additional 20
staff that fully or partially support the Manufactured Food Program in administrative capacities.
The MDA-FFSD, as part of this application, will create a strategic improvement plan that
outlines maintaining full conformance with the MFRPS through maintenance and continuous
improvement. MDA-FFSD will advance national capacity and capabilities for response to food
contamination events through the RRT and maintain a FPTF that provides a forum for all
stakeholders of the state food protection system and maximize the protection of public health
through integration activities. In addition, MDA-FFSD will complete special projects that amplify
MFRPS and RRT work that support FDA's mission and vision for building mutual reliance in an
IFSS.

Public health relevance
Project Narrative The Minnesota Department of Agriculture (MDA) Food and Feed Safety Division (FFSD) seeks to maintain full conformance with the Manufactured Food Regulatory Program Standards (MFRPS) and promote continuos improvement of the standards along with maintaining and documenting Rapid Response Team (RRT) maturity, performance, and growth through advancing national capacity and capabilities for response to food contamination events. Also, the MDA-FFSD will maintain a Minnesota Food Protection Task Force (FPTF) that provides a forum for all stakeholders of the state food protection system and maximize the protection of public health through integration activities. Lastly, the MDA-FFSD will complete special projects that amplify the MFRPS and RRT work that support the Food and Drug Administration's (FDA) mission and vision for building mutual reliance in an Integrated Food Safety System.